The Role of NF-kB in B-Cell Differentiation and Lymphomagenesis

DESCRIPTION (provided by applicant): This research proposal aims to elucidate the mechanisms by which constitutive activation of the nuclear factor-κB (NF-κB) transcription factor complex contributes to the oncogenic transformation of mature B lymphocytes. The majority of B-cell cancers originate from antigen-activated mature B cells that have undergone the germinal center (GC) reaction to generate memory B cells and plasma cells, and the development of several lymphoma subtypes has been linked to the oncogenic transformation of the precursors of memory B cells or plasma cells. Notably, these tumors frequently harbor genetic mutations in NF-κB pathway components that result in the constitutive activation of NF-κB signaling, thus identifying NF-κB as a critical player in GC- lymphomagenesis. These observations underscore the need to elucidate the molecular mechanisms by which NF-κB contributes to the transformation of the tumor precursor cells. NF-κB activation can occur via two different routes, the canonical and the alternative pathways, mediated by specific NF-κB subunits. We have obtained preliminary evidence suggesting that differential activation of the two NF-κB pathways is involved in memory B-cell versus plasma cell differentiation during the GC reaction. Despite extensive knowledge about the biology of NF-κB, its potential function in the differentiation of GC B cells is a novel concept that has not been explored. The objective of the proposed research is to determine the mechanisms by which the two NF-κB pathways and their respective subunits affect the cellular differentiation of memory B-cell and plasma cell precursors in order to understand the biological consequences of a constitutive activation of these pathways in B-cell cancers. Our central hypothesis is that constitutive activation of NF-κB signaling contributes to the pathogenesis of B-cell tumors by disrupting the transcriptional mechanisms that regulate the differentiation of a GC B cell into a memory B cell or a plasma cell. To accomplish the objective of this application, we will define the roles of the separate NF-κB pathways in the differentiation of GC B cells in vivo using conditional mouse models. In addition, we will identify the biological programs controlled by the canonical and the alternative NF-κB pathways in differentiating native GC B cells and in GC-derived tumors of various developmental stages by performing a genome-wide identification of the transcriptional targets. We will also start to determine the extent to which NF-κB is involved in lymphoma pathogenesis in vivo. The rationale for the proposed research is that elucidating the role of the separate NF-κB pathways in GC B-cell differentiation and dissecting the contribution of each pathway to GC-lymphomagenesis will lead to the identification of new prognostic and/or diagnostic markers. Moreover, the results may provide the basis for developing innovative anti-cancer therapies that could reduce the adverse systemic side effects associated with the pharmacological inhibition of the entire NF-κB pathway by specifically targeting constitutive NF-κB signaling at the level of i.) the separate NF-κB pathways, ii.) the individual NF-κB subunits, or iii.) the specific transcriptional targets.

Public health relevance
The proposed research is relevant to public health because Hodgkin and Non-Hodgkin lymphomas as well as multiple myeloma, the majority of which shows constitutive NF-κB activation, often have an unfavorable prognosis and their treatment represents a major challenge for medicine. The rationale for the proposed research is that once the biology of NF-κB in the pathogenesis of B-cell malignancies is known, there will be a basis for developing innovative therapies against lymphoid cancer that are aimed at inhibiting NF-κB. Thus, the proposed research is relevant to the mission of the NIH pertaining to the understanding of the causes of cancer and the subsequent development of effective treatments.